C-Path Global Impact Conference

ABSTRACT
Critical Path Institute (C-Path) is an independent, nonprofit public-private partnership (PPP) with the U.S. Food
and Drug Administration (FDA), with a mission to improve the efficiency and safety of medical product
development. The purpose of the 4-day interdisciplinary conference, titled “C-Path Global Impact Conference”
is to showcase the work done by several C-Path public private partnerships (PPPs) in generating actionable
solutions to accelerate drug development. Additionally, this conference will feature C-Path consortia current
contributions towards the development of novel therapeutics for challenging conditions in neurology, rare and
orphan conditions, and pediatric populations. This conference will be the largest and broadest reaching
conference organized by C-Path during the organization’s nearly 20-year history. The C-Path Global Impact
Conference will bring together and capitalize on the strong existing pre-competitive relationships between C-
Path and diverse stakeholders - including regulatory agencies (U.S. Food and Drug Administration [FDA],
European Medicines Agency [EMA], Japanese Pharmaceuticals and Medical Devices Agency [PDMA]),
pharmaceutical industries, academic researchers, non-profit organizations, and patient groups - to hold
productive dialogue among the conference attendees and advance efforts to produce publicly available drug
development tools to optimize the evaluation of the efficiency and safety of novel therapeutics. This conference
will advance science and clinical practice through the interactive discussions between stakeholders, such as
industry, academia, regulatory agencies, and patient groups. By spurring further productive dialogue regarding
data sharing, standardizing methodologies, and the generation of actionable solutions for drug development
across challenging therapeutic areas, this conference will position C-Path’s PPPs to further accelerate the
development and approval of new therapies, improve clinical trial efficiency, and enhance patient outcomes.

Public health relevance
NARRATIVE The FDA Scientific Conference Grant Program will allow Critical Path Institute (C-Path) to host the “C-Path Global Impact Conference,” an interdisciplinary conference that will capitalize on strong existing collaborations between C-Path and its diverse group of stakeholders, including regulatory agencies (FDA, EMA, PDMA), pharmaceutical industry, academic researchers, non-profit organizations, and patient groups. Topics will focus on the current and future impact of C-Path’s core competencies in data management/science, model informed drug development and analytics, clinical outcome assessments, and biomarkers and how they are applied towards the fields of pediatrics, neurology, and rare and orphan disease. Specific sessions (e.g., regenerative medicine, patient focused drug development (PFDD), and model informed drug development (MIDD) will explain how C-Path can facilitate collaborations in drug development – sharing ideas, expertise, resources, and data – to create drug development tools that can help ameliorate some of the challenges with advancing medical products for underserved populations.